The role of a histone point mutation in pediatric gliomagenesis

PROJECT SUMMARY Pediatric high-grade gliomas (pHGG) are the most common and malignant primary brain tumors in children. Mutations in H3F3A, one of the genes that encodes histone variant H3.3, are definitional for pHGG and H3.3 mutation status correlates with clinical variables such as survival and tumor location. pHGG with a lysine 27 to methionine substitution (H3.3K27M) occur in the brain stem and correlate with particularly poor survival. H3.3K27M is insufficient to drive tumorigenesis in mouse models. However, it co-occurs in humans with PDGFRA activation and TP53 and ATRX deletion, suggesting that H3.3K27M cooperates with these oncogenic mutations to induce tumors. Further, the phenotypic differences between H3.3K27M pHGG and other pHGG suggest differing epigenetic alterations and mechanisms of tumorigenesis. This proposal is focused on identifying the epigenetic and transcriptomic changes induced in murine neural stem cells (NSC) by H3.3K27M and its co-occurring mutations and how those mutations lead to glioma cell phenotypes. To model H3.3K27M pHGG as accurately as possible, I will use an RCAS-TVA-based model in which NSC harvested from Nestin tv-a; Trp53fl/fl or Nestin tv- a; Trp53fl/fl; Atrxfl/fl mice are infected with RCAS viruses encoding Cre recombinase, PDGF?, and H3.3K27M. The resulting NSC will be used to characterize the global and local epigenetic and transcriptomic changes induced by H3.3K27M and its co-occurring mutations in NSC using western blots, ChIP-seq, and RNA-seq. Further, I will characterize the phenotypic changes caused by these alterations using immunocytochemistry, extreme limiting dilution, proliferation assays, and orthotopic allografts. Finally, I will validate the epigenetic and transcriptomic signatures of H3.3K27M mouse NSC in a panel of H3.3WT and H3.3K27M patient derived xenograft (PDX) cell lines via ChIP-seq and RNA-seq, as well as with existing datasets from human tumor samples. These studies will identify mechanisms of pathogenesis for H3.3K27M pHGG and potential epigenetic therapeutic targets that are both tractable in mice and relevant to humans. By completing this research proposal, I will gain technical skills applicable to cancer biology, neuroscience, epigenetics, and biochemistry while also developing my critical thinking, scientific communication, and ethical research skills.

Public health relevance
PROJECT NARRATIVE Pediatric high-grade gliomas (pHGG) are the most common primary malignant brain tumors in children, with poor survival and few effective treatments available. This proposal will model a particularly devastating subset of pHGG that occur in midline brain structures and contain a lysine 27 to methionine mutation in histone variant H3.3 (H3.3K27M), with the goal of determining the effect of this mutation on the epigenetic landscape, transcriptome, and phenotype of mouse neural stem cells. A greater understanding of the pathogenesis of H3.3K27M pHGG will be beneficial both for developing effective treatments for this devastating disease and for knowledge of the role of histones and their modification in normal brain cell development.